Mechanisms of Angiogenic Switch Activation During Wound Repair

DESCRIPTION (provided by applicant): A complete understanding of signals that stimulate angiogenesis, or new blood vessel growth, is essential for promoting vascularization of wounded tissues. Although much evidence supports that growth factors are key in promoting angiogenic responses, much less is known about how other cues from the local environment convert quiescent endothelial cells to sprouting structures. These studies will provide significant new insights and answer as-yet unresolved fundamental issues of how angiogenic growth factors and lipids as well as changes in wall shear stress initiate endothelial sprouting responses in three dimensions. We hypothesize that pro-angiogenic factors stimulate phosphorylation and calpain-dependent cleavage of vimentin, which controls downstream activation of membrane-associated proteinases and initiates sprout formation. These studies will utilize discriminating, defined, quantifiable, three-dimensional systems where primary human endothelial cells invade and form multicellular, capillary-like sprouts. The studies proposed here are expected to demonstrate for the first time that pro-angiogenic factors and wall shear stress combine via calpain and intracellular kinases to disrupt vimentin networks and allow translocation of membrane- associated metalloproteinase to the membrane. These signals result in ensuing invasion and matrix alterations. We will utilize transgenic mice lacking vimentin to confirm the involvement of this intermediate filament in sprouting angiogenesis in the adult. These experiments represent a balanced, multidisciplinary approach to defining the intracellular signals that initiate angiogenic sprout formation in wounded tissue. Integration of defined in vitro and in vivo models of wound healing with intravital imaging will enhance our fundamental understanding of how biochemical and mechanical signals regulate angiogenic sprouting and cell-matrix communication events in 3D, providing a platform for future studies on signals that promote new blood vessel growth in living systems.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE Chronic wounds elicit significant social and economic burdens; therefore, a complete understanding of these events is warranted. This proposal will significantly advance our understanding of how various physiological forces and biochemical signals initiate new blood vessel growth, which is a required step in wound healing. Such knowledge will ultimately aid to decrease the socio-economic burdens associated with aberrations or deficiencies in the process.